Center for Addiction and Disease Risk Exacerbation

Substance use (SU) negatively affects the risk, management, progression, and outcomes of chronic disease and contributes to socioeconomic and racial/ethnic health disparities. Although linkages between SU and chronic disease are well documented, biopsychosocial mechanisms underlying these linkages are poorly understood. Prospective, longitudinal studies that investigate links between SU and chronic disease are needed to inform the development of targeted prevention and intervention efforts. In Phase I, the Center for Addiction and Disease Risk Exacerbation (CADRE) made considerable progress toward establishing a multidisciplinary research center of excellence. With support from our Administrative and Clinical Laboratory Cores, we provided 11 early-stage investigators (ESI) with research funding and career development to support their transition to research independence. Our CADRE team published 612 peer-reviewed articles, 147 of which were directly CADRE-supported, and 4 (of 6) of our initial cohort of Project Leaders (PL) obtained R01s. In Phase II of the CADRE, we propose to continue to support ESIs leading thematically and technically linked studies. Our three initial Phase II PLs will (1) examine effects of alternative nicotine delivery products on smoking, obesity, and relevant clinical outcomes among people with obesity who smoke (Murphy); (2) investigate how sleep and negative affect may mediate the short-and long-term relationship between cannabis use and depression in young adults (Sokolovsky); and (3) investigate the intergenerational effects of parental alcohol use on child externalizing disorders, a predictor of health problems over the life course (Micalizzi). CADRE PLs and Pilot Project Leaders (PPLs) will benefit from mentorship by faculty mentors who will provide guidance on research, publication, and grant writing. The Administrative Core will continue to provide organizational structure and state-of-the-art mentoring; administer the Pilot Projects Program; and lead evaluation of all RPs and center components. The Clinical Laboratory Core will continue to provide research infrastructure and resources to the PLs and PPLs, thereby enhancing investigator productivity and promoting research rigor and reproducibility. Our Recruitment, Engagement, and Community Health (REACH) Core will provide direct support for local, face-to-face and digital recruitment, to help CADRE ESIs meet their enrollment and inclusion goals. Through innovative and interdisciplinary research, the CADRE will contribute new knowledge and continue to serve as the nexus and path toward independence for the next generation of scientists.

Public health relevance
PROJECT NARRATIVE/PUBLIC HEALTH RELEVANCE The research program of this center focuses on the impact of substance use on risk for, development, and progression of chronic diseases. Better understanding of this relationship is expected to benefit individuals with substance use disorders and/or chronic diseases. The center’s projects are led by early career scientists to prepare them for advanced research careers in service of public health.